Developing and Validating a Measure of Patient-centered Peripartum Contraceptive Care

PROJECT SUMMARY ABSTRACT
Background: Contraceptive care is an essential component of maternity care. While patient-centeredness is a
key aspect of the quality of contraceptive care, significant evidence suggests that many pregnant and
postpartum (hereafter “peripartum”) individuals do not receive patient-centered contraceptive care and that
marginalized groups are disproportionately at risk of poor experiences. These poor experiences affect
contraceptive use, birth spacing and risk of adverse birth outcomes. Addressing current shortcomings in
peripartum contraceptive care requires robust metrics grounded in patient-centeredness and health equity, but
no such measures currently exist. Commonly used measures of peripartum contraceptive care focus only on
the clinical outcome of contraceptive provision. Assessing quality through this measure alone—as opposed to
alongside a measure of patient experience—can have unintended consequences of incentivizing the promotion
of contraception use or specific method types over individual patients’ preferences. Thus, there is critical need
for new measures that can capture the patient-centeredness of contraceptive care among peripartum
populations, overall and among key subgroups at disproportionate risk of non-patient-centered care.
Approach: The objective of this proposal is to develop a novel, psychometrically validated measure of the
patient experience of peripartum contraceptive care, the Patient-centeredness of Peripartum Birth control
Counseling (PPBC) measure. To achieve this objective, we will first adapt an existing patient-reported outcome
measure to the unique peripartum context, using modified Delphi methods with patient and expert stakeholders
and cognitive interviews with patients (Aim 1). We will then administer the prototype measure developed in Aim
1 to a large sample of peripartum individuals, to assess and confirm factor structure, evaluate reliability and
external validity, and develop a refined measure of the patient experience of peripartum contraceptive care
(Aim 2).
Impact: Findings from this proposal hold promise to ultimately transform the ability of health systems and
researchers to understand and promote patient-centered, equitable peripartum contraceptive care delivery and
thereby improve health outcomes for the 4 million mothers and infants receiving perinatal care in the U.S.
annually.

Public health relevance
PROJECT NARRATIVE Mounting evidence suggests poor patient experiences with peripartum contraceptive care. Validated quality metrics grounded in patient-centeredness and health equity could help drive efforts to improve these crucial domains of healthcare quality, but no such measures currently exist. We will use modified Delphi methods with patient and expert stakeholders, cognitive interviews with patients, and psychometric testing to generate a novel measure of the patient experience of contraceptive counseling within the unique context of maternity care, with a goal of ultimately transforming the ability of health systems and researchers to understand and promote patient-centered, equitable peripartum contraceptive care delivery and thereby improve health outcomes for mothers and infants.